Protocol Review and Monitoring Committee

The Moores Cancer Center (MCC) Protocol Review and Monitoring System (PRMS) oversees and provides
independent, peer review of the scientific merit, priority, and progress of all cancer studies
involving human subjects conducted at the University of California, San Diego, its affiliated Rady
Children's Hospital as well as cancer-related population sciences research conducted at MCC's
consortium partner, San Diego State University. PRMS functions are accomplished by
rigorous review in a 2-stage process conducted by:
1) MCC multidisciplinary Disease Teams, where initial assessment of value, fit, and
prioritization within the existing portfolio of studies is performed as well as an assessment
of each study's operational and accrual feasibility; and 2) the Protocol Review and Monitoring
Committee (PRMC), which is the definitive independent authority for determining which studies
proceed to activation. The Disease Teams' input and approval are required before
proceeding to the PRMC; however, only the PRMC has final and independent authority with regards to
determining which studies will be activated and which underperforming studies will be closed. The
PRMC has the primary goal to ensure that all MCC-aligned cancer research studies involving human
subjects are: 1) scientifically sound; 2) effectively designed, specifically from a biostatistics
perspective; 3) appropriately prioritized within MCC's Disease Teams' research portfolios to avoid
competing trials as well as aligned with MCC's overall institutional priorities for clinical
research; 4) feasible for completion or in meeting institutional accrual goals; 5) assessed for the
adequacy of the data and safety monitoring plans based on the risk level of the study; and 6)
monitored regularly for accrual and scientific progress. In 2017, the MCC Disease Teams have vetted
in aggregate 198 studies and forwarded 165 of these studies to PRMC review. Once received by the
PRMC, 46 of these studies received an initial expedited review by the PRMC Chair, Vice Chair, or a
PRMC designee as they had already received an appropriate external scientific peer-review, and 119
of these studies, primarily representing MCC's investigator-initiated and industry-sponsored
trials, were forwarded for full PRMC review. More than 22% of the studies reviewed by the PRMC
required modifications prior to being approved, and 3 studies were disapproved and not allowed to
proceed through the activation process. In addition, the PRMC also conducted scientific and accrual
progress reviews for all actively accruing MCC studies for which 24 underperforming studies were
closed in 2017. The MCC PRMS, inclusive of the Disease Team and PRMC review processes, is one of
the most critical functions that the MCC performs to ensure the highest quality of research is
being conducted at MCC.